The translational potential of next-generation sporadic mouse and human models of ALS/FTD

ABSTRACT/SUMMARY
Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are now thought to lie within a shared
umbrella of neurodegenerative disorders, all characterized by neuronal loss, behavioral deficits, and ultimately
death with no truly effective treatments. It is now generally well recognized that TDP-43 dysfunction (both loss
and gain of function) represents the major disease hallmark that is linked the onset and progression of these
devastating diseases. However, modeling ALS/FTD has been particularly challenging, in part since slightly too
much or too little TDP-43 is toxic to neurons. Our goal for this R61/R33 proposal is to develop and optimize a
new ALS/FTD animal model that more accurately recapitulates the human disease spectrum. This model is
based on the unanticipated finding that TDP-43 can undergo acetylation on its lysine residues, and that this
specific post-translational modification (PTM) has a dramatic effect on TDP-43; it disengages TDP-43 from its
target RNAs, promotes its aggregation, and leads to the loss of normal nuclear TDP-43 function. Based on this
mechanism, we developed a new CRISPR-integrated mutant mouse line that incorporated an acetylation-
mimicking substitution (KàQ) at position K145 in the endogenous mouse TARDBP locus, thereby generating
TDP-43K145Q mutant mice, and we observed many striking hallmarks of disease including aggregated TDP-43,
widespread transcriptomic and splicing alterations, and cognitive decline. These mice should provide the ideal
platform for biomarker therapeutic development opportunities, not just for sporadic ALS/FTD, but potentially
any neurodegenerative disease within the TDP-43 umbrella characterized by abnormal TDP-43 deposition.
The goal of this R33/R61 proposal is to extend and optimize the readouts to demonstrate a progressive
ALS/FTD-like phenotype using aged mouse cohorts (R33 phase) and subsequently externally validate our
animal findings with those in human models, including postmortem ALS/FTD tissues and iPSC-derived
neurons (R61 phase). The use of iPSC-derived sporadic ALS “trio” lines, in which the lysine residue of interest
(K145) is targeted, should provide insight into causality of TDP-43 acetylation as a driver of sporadic ALS/FTD.
This study is ideal for the R61/R33 mechanism, since it will highlight TDP-43K145Q mice and newly developed
iPSC lines as next-generation sporadic ALS/FTD models that could radically transform the field and provide
new platforms for therapeutic testing of drug candidates.

Public health relevance
PROJECT NARRATIVE Developing and optimizing new ALS/FTD animal models that more accurately recapitulate the human TDP-43 proteinopathy disease spectrum has been very challenging. We can now leverage the finding that TDP-43 undergoes lysine acetylation to build next-generation ALS/FTD models, as we have done with our recently generated TDP-43K145Q mutant mice, that show many striking hallmarks of disease. These mice, and their parallel human iPSC lines, could radically transform the field and provide new platforms for both biomarker development and therapeutic testing of any emerging drug candidates, not just for sporadic ALS/FTD, but potentially other related neurodegenerative diseases as well.